A Randomized Trial of Incentives and Peer Mentors to Improve Diabetic Outcomes

DESCRIPTION (provided by applicant): In recent years, social networks have garnered attention in both academic journals and the lay press because of strong associations demonstrated in retrospective studies between social networks and incidence of major health problems such as obesity and smoking. Financial incentives have also been demonstrated to improve health behaviors in obesity, smoking, and medication adherence. We propose to conduct a randomized controlled trial among a predominantly African American population with persistently poor DM control to examine whether two novel interventions, lottery based financial incentives and telephone based one-on-one peer mentoring (the 'buddy system'), can significantly ameliorate disparities in poor DM control. The intervention is based on epidemiologic evidence, randomized controlled trials, and pilot studies demonstrating: 1) Lottery based financial incentives are a powerful motivator of behavior change;2) One-on- one peer mentoring is a flexible, cost-efficient means of increasing DM specific social support and may be particularly salient in minority communities;and 3) Matching patients with poorly controlled DM with a similar individual from their community who has gained control of their DM draws on existing community assets in creating an inherently culturally competent intervention. DM patients with poor DM control will be randomized to 1 of 4 arms: usual care;telephone based one-on-one peer mentoring;lottery based financial incentives;and peer mentoring plus financial incentives. The Specific Aims are to test: 1) The effectiveness of telephone based one-on-one peer mentoring in improving glycemic control relative to usual care;2) The effectiveness of lottery based financial incentives in improving glycemic control relative to usual care;3) The effectiveness of combining peer mentoring and financial incentives relative to control;and 4) The relative cost effectiveness of all four approaches. In exploratory analyses, we will examine whether African American patients enrolled in intervention arms have greater improvement in glycemic control than white patients, whether intervention group patients experience greater improvements in blood pressure (BP) and lipid control, and whether peer mentors experience improvements in their own health. We will pair mentors with mentees based on race, gender, age, and disease severity. The active intervention will be run for a 6-month time period, with participants followed for an additional 6 months to determine if effects persist post intervention. The proposed interventions address multiple barriers to effective disease management common among patients with DM. If effective, these interventions could provide important models for improving glycemic control in general and, in particular, for addressing racial disparities in DM outcomes. PUBLIC HEALTH RELEVANCE: We will perform a randomized controlled trial in a predominantly African American population from West Philadelphia with poorly controlled diabetes evaluating the effectiveness of: one-on-one peer mentoring, financial incentives, and one-on-one peer mentoring plus financial incentives in improving glucose control. The proposed interventions address multiple barriers to effective disease management common among patients with diabetes. If effective, these interventions could provide important models for improving glucose control in general and, in particular, for addressing racial disparities in diabetes outcomes.

Public health relevance
PROJECT NARRATIVE We will perform a randomized controlled trial in a predominantly African American population from West Philadelphia with poorly controlled diabetes evaluating the effectiveness of: one-on-one peer mentoring, financial incentives, and one-on-one peer mentoring plus financial incentives in improving glucose control. The proposed interventions address multiple barriers to effective disease management common among patients with diabetes. If effective, these interventions could provide important models for improving glucose control in general and, in particular, for addressing racial disparities in diabetes outcomes.